Project-Pilots

The central goal of the Pilot Core of this proposed Roybal Center is to launch and complete NIH Stage 0-III
studies that position Center investigators to compete for independent funding for Stage IV-V effectiveness and
implementation trials of interventions to improve palliative care for persons with dementia (PWD) in long-term
services and support (LTSS) facilities. To achieve its primary goal of selecting and supporting pilot projects that
translate ideas from behavioral economics and data science into improvements in care for PWD residing in
LTSS facilities, the Steering Committee will issue an annual request for applications to all Affiliated
Investigators and their trainees. Pilot Core PI Jason Karlawish, MD and other Committee members will rate
each application on seven criteria and assign each an overall score using the 9-point NIH scale. The
Committee will then propose the highest-scored pilots for final funding decisions to (1) the Roybal Center's
Advisory Committee; (2) the Genesis HealthCare leadership (for projects proposing studies within Genesis
facilities); and (3) NIA officials and the Roybal Coordinating Center.
The Pilot Core has three other specific aims. First, we aim to mentor junior faculty and post-doctoral fellows in
developing and testing behavior change interventions. Several Steering Committee members and numerous
Affiliated Investigators are leading behavioral research mentors, and have committed substantial portions of
their careers to mentorship. We expect junior investigators to feature prominently in at least half of the pilot
projects supported through this Center, and will use the Center's annual Symposium to launch new mentoring
relationships among junior and senior investigators. Second, we aim to foster new collaborations among the
Center's Affiliated Investigators, particularly by linking those with expertise in Stage 0-III behavioral intervention
research with investigators who possess methodological expertise in behavioral economics, data science,
qualitative methods, statistics, and implementation science. These collaborations between behavioral scientists
and methodologists will enable us to develop scalable interventions that measurably improve outcomes.
Third, the Pilot Core will provide centralized data and safety monitoring plans and oversight for all Roybal
Center pilots. Pilot Core PI Karlawish and Overall PI Halpern are both experts in research ethics. In
conjunction with the Center's highly experienced senior staff, they will develop data and safety monitoring
plans for all pilot projects as a shared resource of the Center. This pilot core proposes a Stage I and a Stage 0
project for funding in year 1, and describes these projects in detail. These two pilot projects were selected
following an initial call for applications in preparation of this Center proposal. Although this initial call operated
on an abridged timeline, many exceptional applications were submitted. We therefore also provide brief
descriptions of four other exemplary proposals that will be considered for funding in future years.